Preclinical development of CXCR6 antagonists to target sorafenib resistance in Hepatocellular Carcinoma

PROJECT SUMMARY/ABSTRACT
Sorafenib (Nexavar®) is the first FDA approved targeted drug for advanced hepatocellular
carcinoma (HCC) patients and a first-line treatment. However, it offers only a moderate life
extension in about 40% of advanced unresectable HCC patients due to low response rate, serious
adverse events and acquired resistance. Some of the cellular pathways associated with HCC
development and poor prognosis also cause resistance to sorafenib. Understanding which
pathway will have monumental impact by providing HCC specific clinical biomarkers of response
and the development of new therapeutic targets. One such pathway dysregulated in 50% of HCCs
is the activation of Wnt/β-catenin, induced by kinase cascades, notably the Ras/Raf/Mek/Erk
(targeted by sorafenib), PI3K/AKT/TOR and p38 MAPK leading to inactivation of GSK-3β kinase.
Post its escape from phosphorylation by GSK-3β and proteasomal degradation, β-catenin
accumulates in the nucleus and activates transcription of several oncogenic proteins rendering
sorafenib ineffective and promotes unchecked anti-apoptosis, cell proliferation, angiogenesis,
EMT and invasion. A novel strategy proposed by us for combating resistance to sorafenib involves
inhibiting hyperactivation of a chemokine receptor CXCR6. Signaling from CXCR6 and its ligand
CXCL16 drives resistance to sorafenib through the downstream kinases and culminates at Ser-9
phospho-GSK3β/β-catenin activation. CXCR6-knockdown in SK-Hep-1 and other hepatoma cell
lines is correlated with lower p38 activity, increased GSK3β activity, membrane sequestration of
β-catenin and downregulation of β-catenin transcriptional activity in the nucleus. We have
developed a first-in-class small molecule lead, SBI-457, that antagonizes the CXCR6 receptor, is
orally bioavailable in mice and efficacious at attenuating tumor growth in a 30-day mouse
xenograft model for advanced HCC with no adverse effects. Since CXCR6/CXCL16 are not highly
expressed in non-cancerous hepatocyte and other liver tissue, SBI-457 is expectedly non-toxic in
vivo under high dose and chronic exposure. Since there are no known clinical CXCR6 antagonists
to date, optimization of lead SBI-457 as a single agent in advanced HCC will be the first innovative
aspect of our application. A second major innovation is a combination of optimized CXCR6
antagonists with sorafenib in resistant HCC cells to understand and then overcome the major
bottleneck of chemoresistance. Hence small molecule CXCR6 antagonist leads developed in this
application have the potentially to expand the clinical use of sorafenib and other targeted agents
by re-sensitization, improved response, and lowering of the dose thereby reducing toxicity and
risk of adverse events.

Public health relevance
PROJECT NARRATIVE Chemokine receptor CXCR6, and its native ligand CXCL16 drive resistance to sorafenib, an FDA approved first-line treatment in advanced stage hepatocellular carcinoma (liver cancer) by overriding growth checkpoints and leading to tumor progression and metastasis. This application seeks to optimize, non-toxic small molecules to block CXCR6 signaling that are derived from SBI- 457, a leading candidate developed previously by our team by studying relationships of the chemical structure to biological activity and drug-like properties and making iterative improvements. The application aims to use SBI-457 and optimized molecules in combination with sorafenib to overcome resistance and improve patient response.